Nuclear Organization and Function

PROJECT SUMMARY. Proper regulation of gene expression is essential for cell differentiation and
homeostasis. Most of our understanding of the mechanisms that control the transcription process comes from
studies of the one-dimensional genome i.e. the 10 nm chromatin fiber. However, the genome is folded in the
three-dimensional (3D) nuclear space, and the relationship between this organization and gene expression is
poorly understood. Using Drosophila as a model system, where it is feasible to obtain 250 bp resolution Hi-C
data, we have found that the genome is folded into only one type of domain, which we call compartmental
domains. These domains precisely correlate with the transcriptional state of their sequences. Compartmental
domains are also found in other lower eukaryotes. Based on this, we propose that compartmental domains
represent an evolutionarily conserved principle of genome 3D organization. Drosophila and lower eukaryotes
either lack CTCF or this protein is unable to stop cohesin extrusion. However, CTCF can interfere with the
progression of cohesin extrusion in vertebrates, which in turn affects other types of interactions in the genome.
Here we suggest extending concepts learned from the analysis of 3D organization in Drosophila to mammals
by proposing an ambitious and substantive multi-disciplinary approach combining genetics, epigenomics,
computational biology, and differentiation of human embryonic stem cells (hESC) into disease-relevant tissues.
The hypothesis underlying the proposed experiments is based on the idea that, rather than the prevalent view
of large compartments containing smaller TADs, the mammalian genome is organized by conserved principles
into relatively small compartmental domains. Cohesin extrusion operates on top of the compartmental domain
scaffold and affects its organization. To test this novel hypothesis, we will deplete specific proteins present in
complexes required for various aspects of the transcription process. We will also deplete protein complexes
responsible for H3K27me3- and H3K9me3-dependent silencing. We will then use Micro-C XL to obtain very
high-resolution interaction data and examine effects of protein depletion on the formation of self-interacting
domains and in the interactions between these domains. These effects will be examined in the presence and
absence of cohesin in order to understand the contribution of loop extrusion to enhancer-promoter interaction
frequency. We will examine the predictability of 3D genome organization from one-dimensional epigenetic
information using machine learning computational tools. We will study the logic of CTCF loop formation by
analyzing the local chromatin environment around CTCF sites able or unable to form loops of different
strengths using a new computational tool we have developed. Principles learned from these experiments will
be tested by analyzing changes in 3D organization and their relationship to gene expression during the
differentiation of hESCs into pancreatic cells. Results from this work will fill critical gaps in our understanding of
the relationship between 3D chromatin organization and transcription, and its possible role in human disease.

Public health relevance
PROJECT NARRATIVE This study will analyze the mechanisms by which the three-dimensional organization of the genetic material in the nucleus is established and maintained. This organization is critical for the regulation of gene expression, and the results will be important to understand how transcription is controlled during stem cell differentiation or during reprograming of somatic cells. This knowledge will be essential to understand the basic biology of the cell nucleus and the origin of human genetic disease or cancer and could help guide the use of stem cell therapy to treat human diseases.